Estimating the population size of persons who inject drugs in New York

ABSTRACT
Injection is an increasingly common route of administration for opioids and other drugs in the U.S. Unsafe
injection drug use (IDU) behavior threatens recent progress made in reducing HIV and hepatitis C virus (HCV)
infections among persons who inject drugs (PWID), which is a major impediment to achieving ambitious
national goals for reducing new HIV infections. During the past decade, New York State has experienced
growing rates of opioid use disorder and, consequently, increases in IDU-related infectious diseases. New
York has strong political will to reduce the burden of these infections among PWID and is the first U.S. state to
commit to both “Ending the AIDS Epidemic” and HCV elimination strategies. However, New York, like other
states, does not have a current, statewide estimate of how many PWID need infectious disease prevention
services. Robust estimates of PWID population sizes are needed in New York and elsewhere to facilitate
optimal allocation of scarce resources, measure risk-specific infectious disease burden among PWID, and
assess coverage of prevention interventions. We propose to estimate PWID population size and associated
risk-specific disease and prevention intervention coverage rates in New York using multiple systems estimation
(MSE) with a combination of extant administrative and PWID survey data. MSE is an application of capture-
recapture methods that allows estimation of underlying population size using joint probabilities of observing
individuals in linked administrative datasets vis-à-vis their receipt of a service or diagnosis. We will apply MSE
methods to linked, statewide datasets in New York including claims data, inpatient and emergency room
electronic hospital records, drug treatment program data, and infectious disease surveillance data. We will also
improve the rigor of MSE methods by addressing potential violations of key statistical assumptions through
augmented estimation models, partially informed by survey data currently being collected by the study team.
Our Specific Aims are: (1)To estimate PWID population size in New York State using MSE with indications of
current IDU behavior from linked administrative datasets, overall and by region, sex, and age; (2) To create
refined PWID population size estimates accounting for bias due to unequal probabilities of observing
individuals in datasets; (3) To allocate state PWID population size to all 62 counties using a standardization
modeling approach; (4) To compute key epidemiologic indicators needed to measure infectious disease risk
among PWID: risk-specific HIV and HCV diagnosis rates, syringe service program utilization rates, and number
of PWID initiating IDU during past year; (5) To disseminate estimates and methodology using the AIDSVu data
visualization platform. The national impact of this work, using New York as a model, will be to establish a
robust, replicable method for producing estimates that can guide efforts to improve PWID health and reduce
the burden of HIV and HCV in this high-risk, under-studied group.

Public health relevance
Project narrative Injection is an increasingly common route of administration for opioids and other drugs in the U.S. and increases risk for infectious diseases such as HIV and hepatitis C virus. However, there are no state-level estimates of how many people inject drugs or their characteristics, making infectious disease prevention programs difficult to plan, implement, and monitor. In this project, we will use big data to create estimates of the size of the population injecting drugs in New York, and these estimates will serve as a model for other states aiming to address the infectious disease consequences of the opioid crisis.